The role of PRMT5 in preventing intra-chromosomal deletions in cancer cells

Project Summary/Abstract
PRMT5 is an arginine methyltransferase with key roles in cancer. The gene has pleiotropic functions ranging
from gene regulation and development to modulation of DNA double strand break (DSBs) repair. In S-phase and
mitosis, DSBs are repaired primarily by homologous recombination (HR) a process in which missing genetic
information is copied from another undamaged chromosomal region. In humans, error-free HR is mediated by
BRCA1, BRCA2 and RAD51. RAD52, an accessory gene, facilitates an error-prone HR sub-pathway that can
produce intrachromosomal deletions (ICDs). PRMT5 appears to modulate chromatin remodeling at the DSB
through the error-free BRCA1/2-RAD51 pathway.
In fission yeast (S. pombe), we identified physical and genetic interactions between PRMT5 and RAD52. Deletion
of PRMT5 increases the frequency of ICDs while deletion of RAD52 decreases ICDs suggesting that they have
opposite functions. In cancer cells PRMT5 mutations increases the size of ICDs. Using artificial intelligence
algorithms, we discovered multiple likely pathogenic mutations including three driver mutations in the active
site of PRMT5 that are likely to destabilize the function of the enzyme.
We hypothesize that PRMT5 inhibits ICDs by biasing repair of DNA double strand breaks
toward conservative pathways.
We developed innovative in vivo assays to probe HR repair mechanisms that produce ICDs. The repair
mechanisms and factors involved are conserved from yeast to humans making the S. pombe model system highly
tractable. A homology analysis reveals that all identified human mutated residues are present in yeast.
In Aim1 we will place PRMT5 in the DNA damage repair epistatic pathway using mutational analysis and
sensitivity to various DNA damage drugs. Additionally, we will employ in vivo repair assays to understand the
HR pathways by which ICDs are produced in the absence of the PRMT5 function. In Aim 2 we will analyze
PRMT5 mutations identified in cancer cells using the Catalogue of Somatic Mutations in Cancer (COSMIC). We
will employ modeling techniques and enzymatic assays to test how these mutations affect the enzymatic function
of PRMT5 and DSB repair. Most of these mutations are conserved in yeast making this analysis tractable. The
findings will be further validated in human cells.

Public health relevance
Project narrative Cancers are characterized by deletions of chromosomal regions some of which can inactivate cell cycle regulators while the role of others is not known. This proposal investigates the role of PRMT5, a gene central to cellular proliferation and carcinogenesis, in suppressing chromosomal deletions in human cells. Successful completion of the proposed experiments will delineate new mechanisms of cellular transformation and carcinogenesis.